SCH: A structural causal framework for adaptive experiments

Adaptive randomized clinical trials are critical in infectious disease research, offering flexibility to adjust
sample sizes, introduce new interventions, discontinue ineffective treatments, and target specific
subgroups to enhance treatment efficacy. This adaptability is particularly valuable in rapidly evolving public
health crises, such as the development of treatments for emerging infectious diseases like COVID-19.
However, adaptive trials present significant challenges, including unclear inferential targets, statistical
biases from temporal and spatial variability, complexities in handling dynamic data structures, and an
increased risk of false-positive findings. These concerns are reflected in recent FDA guidance on
estimands, which emphasizes the need for clearly defined inferential targets, and on adaptive designs,
which acknowledges that statistical bias in adaptive trials remains an understudied issue. Despite these
recognized challenges, current research lacks a principled framework for structurally representing and
unbiasedly estimating causal effects in adaptive trials. This project will develop a structural causal
framework for adaptive trials, leveraging modern causal inference and statistical techniques alongside
secondary data from the Adaptive COVID-19 Treatment Trial (ACTT)—an adaptive trial evaluating novel
therapeutics in hospitalized COVID-19 patients—to enable transparent, efficient, and statistically unbiased
estimation of causal effects.
To achieve this, we propose the following specific aims:
Aim 1: Develop a structural causal approach that deals with temporal variability.
Aim 2: Extend our framework to handle spatial variability.
Aim 3: Expand our framework to handle complex data structures, including failure-time and missing data,
while dealing with false-positive results.
Our project aligns with NIAID’s mission by advancing key methodologies for infectious disease clinical
trials, particularly in adaptive designs for pandemic response, emerging pathogens, and the development of
antiviral treatments. While our primary focus is on infectious disease trials, our methods have broader
applicability to other disease areas, such as schizophrenia. We show this by also leveraging secondary
data from schizophrenia studies, including the DECIFER trial, the RAISE study, and the EPINET study.
RELEVANCE (See instructions):
This research aims to improve how adaptive clinical trials are designed and analyzed. By developing
methods that address key challenges in adaptive trials, our work will help ensure more accurate and
reliable results, ultimately leading to better treatments and public health responses to emerging infectious
diseases.